Yeast Ribosome Biogenesis

PROJECT SUMMARY/ABSTRACT
Ribosomes are complex ribonucleoprotein particles that catalyze protein synthesis in almost
all cells in nature. The long-term goal of this project is to understand how the 80 proteins and
four rRNAs comprising eukaryotic ribosomes are assembled in vivo. We use the yeast
Saccharomyces cerevisiae to facilitate molecular genetic approaches, and cultured Hela cells to
enable us to visualize the nucleolus, the cellular compartment where ribosomes are made.
Production of ribosomes is tightly linked to cell growth and proliferation. Consequently,
dysregulation of ribosome biogenesis and nucleolar integrity is linked to many diseases such as
cancer, neurodegenerative diseases, or developmental disorders. Because pathways of
ribosome biogenesis are very conserved, our studies in yeast will help understand mechanisms
of regulation and dysregulation of ribosome production in humans.
Ribosome biogenesis requires a dynamic series of remodeling steps in which protein and RNA
interactions are established and reconfigured. These steps are made more efficient and more
accurate by the activities of more than 200 assembly factors present in nascent yeast ribosomes,
which are required for their assembly, and conserved across eukaryotes.
To enable in-depth studies of mechanisms driving ribosome assembly, we focus on one
interval: just prior to, during, and immediately after exit of large ribosomal subunit precursors
from the nucleolus into the nucleoplasm. During this stage, several domains of ribosomal RNA
are rearranged, numerous assembly factors complete their functions and exit from pre-ribosomes,
and new assembly factors enter the particles. We want to learn how these dynamic remodeling
steps are powered forward by energy-consuming assembly factors present at this stage.
We are also investigating interconnections between ribosome assembly and the nucleolus, the
prominent biomolecular condensate thought to be formed through multivalent interactions
between pre-ribosomes and other nucleolar components. However, it is not clear exactly how
ribosome assembly creates a nucleolus, nor how material properties of the nucleolus enable
efficient ribosome assembly.
We propose experiments to address the following questions: (1) How do the RNA
helicases/ATPases Drs1, Has1, Dbp10, and Spb4 power maturation of pre-60S subunits during
mid to late nucleolar stages of assembly? (2) How does the structure and composition of pre-
ribosomes enable them to be retained in the nucleolus? (3) How does ribosome assembly
contribute to the morphology and fluidity of the nucleolus?

Public health relevance
PROJECT NARRATIVE This proposal describes research to study how ribosomes are assembled in yeast and Hela cells, and how ribosome biogenesis is interconnected with the structure and function of the nucleolus, the cellular compartment where ribosomes are made. As the ribonucleoprotein machines that catalyze protein synthesis in all cells, ribosomes are essential for and closely linked to the growth, proliferation, and adaptation of cells. Consequently, dysregulation of ribosome synthesis or nucleolar structure results in cancers, anemias, neurodegenerative diseases, and a variety of developmental disorders.